AI-powered engineering and analysis of cyanobacterium vesicles targeting gastrointestinal cancer

AI-powered engineering and analysis of cyanobacterium vesicles targeting gastrointestinal cancer
ABSTRACT
Gastrointestinal (GI) malignancies, such as gastric, colon, liver and pancreatic cancers, represent
some of the most common and deadly cancers worldwide. There are over 5000 clinical trials testing
therapeutic candidates for GI cancers. Unfortunately, 75-80% of drug candidates fail due to efficacy
and/or safety issues associated with ineffective in vivo delivery. This is particularly the case for
biologicals such as RNA and protein therapeutics. There is thus an urgent need for developing a)
precision drug delivery vehicles to increase the success rates of RNA and protein drugs and b)
scalable biomanufacturing platforms that can provide sustainable treatment solutions.
Here we propose such a platform based on reprogramming membrane vesicles from the
cyanobacterium Spirulina (Arthrospira platensis). The platform combines advantages of i) state-of-
the-art AI protein design algorithms, ii) sensitive and rapid vesicle analysis and iii) a well-tolerated,
edible microbial production system, to improve targeted and oral delivery of RNA therapeutics for
gastrointestinal cancer. In Aim 1, we will apply AI pipeline to design new vesicle scaffold proteins and
test for membrane anchoring and target binding. Subsequently in Aim 2, we will engineer Spirulina
vesicles and assess cellular uptake in human cancer cell lines. The Phase I proposal will focus on
engineering vesicles to enable targeted RNA delivery to CLDN18.2-positive cancer cells of the GI
origin. We envision this programmable spirulina vesicle platform as a transformative technology to
help i) accelerate the development of RNA-based therapeutics for GI cancers (e.g. RNAs for tumor
suppressor p53, PROTAC targeting oncogenic KRAS), and ii) improve oral delivery and precision
treatments to better patient outcomes.

Public health relevance
PROJECT NARRATIVE We will combine AI-powered vesicle design, automated vesicle analysis, and a low-cost, edible microbial production system, to accelerate the development of targeted RNA therapeutics for gastrointestinal cancer.